Behavioral and physiological measurements of hearing in mouse models of Alzheimer's Disease

Project Summary
Although Alzheimer’s disease and related dementias (ADRD) and hearing loss often co-occur, the nature of
this relationship is still largely unknown. Many mouse models have been developed to better understand the
physiological and behavioral effects of specific ADRD-related brain pathologies, but the research on hearing
in these mice lags human studies and has not produced definitive results, with huge variability across
laboratories. One study suggested that exposure to damaging noise may exacerbate the ADRD pathology
in one ADRD model mouse strain, but other labs have not found similar effects in other mouse strains.
Further, most researchers pursuing information about hearing, hearing loss, and aging in mouse models of
ADRD utilize physiological methods in anesthetized mice or reflexive methods to assess hearing status.
While these techniques are informative, neither method accurately portrays how an awake, behaving
organism perceives the world around them. This is critical because epidemiological and audiological studies
of humans with ADRD, as well as healthy-aging humans, rely primarily on behavioral measures of hearing
dysfunction. For this reason, hearing in quiet and in noise at several time points in the mouse lifespan in
three mouse models of ADRD using behavioral psychoacoustic assessments and physiological evoked
potential techniques will be conducted. Comparisons of results from male and female mice trained with
operant conditioning and positive reinforcement to those from anesthetized and unanesthetized mice using
auditory brainstem response and middle latency response recordings will be made. Comparisons of
behavioral results to physiological measurements will provide information about whether behavioral
performance reflects central compensation processes and which physiological test conditions correspond to
behavioral deficits. These experiments will help to better appreciate how aging, sex, and noise affect
communication in mice, possibly leading to advances in understanding communication issues in human
patients suffering from ADRD.

Public health relevance
Project Narrative These experiments will address a significant gap in what we know about the causal link between hearing loss and Alzheimer’s disease by using mouse models with specific brain pathologies. Most studies on the effects of age, sex, and noise using these models test them with physiological and reflexive techniques, which do not accurately reflect how sounds are perceived in an awake, behaving state akin to people out and about in the world. This study aims to characterize the relationship between behavioral and physiological measures of hearing in quiet and noisy environments to learn more about the relationship between hearing loss and Alzheimer’s Disease.